Toxicity of saxitoxin congener mixtures in shellfish from Southeast Alaska

PROJECT SUMMARY / ABSTRACT
Project 2 of the Knowledge Warding Against Toxin Levels Center will be co-led by Kari Lanphier, head of the
Southeast Alaska Tribal Ocean Research Consortium, and Dr. Thomas Webster, an environmental health
academic expert on chemical mixtures. The purpose of Project 2 is to evaluate different estimates of the
toxicity of the saxitoxin congeners in shellfish. Specifically, Project 2 will (1) Compare predictions of shellfish
saxitoxin-related toxicity using a bioassay (RBA) measuring total toxicity with estimates based on
measurement of individual saxitoxin congeners (via HPLC) plus Toxic Equivalency Factors (TEF) from
FAO/WHO; (2) test whether saxitoxin congeners adequately predict RBA using the TEF model; and (3)
improve TEF estimates by regressing RBA against saxitoxin congener concentrations using new mixtures
methods.